National Centralized Repository for Alzheimer's Disease and Related Dementias (NCRAD)

Project Summary/Abstract
This administrative supplement outlines the critical role of the National Centralized Repository for
Alzheimer’s Disease and Related Dementias (NCRAD) in establishing a centralized, high-quality
resource of induced pluripotent stem cells (iPSCs) developed as part of the U54 Centers funded
under RFA-AG-040. As the prevalence of Alzheimer’s disease and related dementias (ADRD)
continues to rise, understanding the complex genetics and pathophysiology of Alzheimer’s
disease (AD) and ADRD is paramount. Animal models were the primary approach used for
functional genomics; but with small effect risk loci and the difficulty of recapitulating AD in animal
models, there is a new focus on cellular models. Induced pluripotent stem cells are of particular
interest since they can differentiate into a variety of central and peripheral nervous system cell
types. NCRAD has a proven track record in banking and distributing DNA samples that have
facilitated significant genetic discoveries. As the field shifts towards cellular models, particularly
iPSCs, NCRAD is uniquely positioned to serve as the central repository.
This supplement proposes to standardize and centralize the collection, storage, and distribution
of iPSCs generated by new U54-funded initiatives. Key innovations include NCRAD's existing
expertise with iPSCs and its established infrastructure for integrating iPSCs with rich clinical data
from studies like ADNI. The revised approach focuses on the following main aims: developing
comprehensive standard operating procedures (SOPs) for both sample submission (Aim 1) and
sample distribution (Aim 2). This includes creating detailed manuals of procedures, establishing
robust data linking protocols with other repositories (e.g., AD Knowledge Portal, NIAGADs, LONI),
and refining a review process for iPSC requests. Finally, Aim 3 addresses the operational
implementation of these procedures for the efficient and standardized receipt of new iPSC
resources. By centralizing this critical resource, NCRAD will significantly accelerate ADRD
research, foster reproducibility, and facilitate the discovery of novel therapeutic targets.

Public health relevance
Project Narrative This administrative supplement positions NCRAD as a vital resource for accelerating Alzheimer's disease and related dementias (ADRD) research by establishing a centralized, high-quality induced pluripotent stem cell (iPSC) repository. The project will operationalize robust procedures for iPSC submission and distribution, integrating them with existing clinical and genetic data. By standardizing practices and enabling data linkage, NCRAD will foster reproducibility and facilitate the discovery of new therapeutic targets for the millions affected by ADRD.